Using automated speech processing to improve identification of risk for hospitalizations and emergency department visits in home healthcare

PROJECT SUMMARY
Every year, about 11,000 home healthcare (HHC) agencies across the United States provide care to more
than 5 million older adults. Currently, about one in three HHC patients are hospitalized or visit an emergency
department (ED) and up to 40% of these events are preventable with appropriate and timely care. However,
these numbers have not improved over the last decade, despite national and local quality improvement efforts.
Recent advances in a subfield of data science—automated speech processing—have unlocked an
untapped rich data stream that can improve risk identification by analyzing nurse-patient verbal
communication. The proposed study brings together an interdisciplinary team of experts in home healthcare
nursing, automated speech processing, natural language processing, and risk model development to explore
whether automated speech processing can improve timely identification of patients at risk in home healthcare
and potentially reduce their hospitalizations and ED visits.
Specifically, the aims of this study are: Aim 1: Refine and finalize an automated speech processing system
to identify hospitalization and ED visit risk factors in patient-nurse verbal communications. Aim 2: Explore to
what extent data extracted from patient-nurse communications can improve risk prediction for hospitalizations
and ED visits, when compared against the risk model based on electronic health record data only.
This study will build a first-of-a-kind hospitalization and ED visit risk model that automatically incorporates
data from patient-nurse verbal communication. In future work, this risk model can be integrated into home
healthcare clinical workflows to trigger timely and personalized alerts about concerning patient trends, which
will in turn activate appropriate and timely care to prevent avoidable hospitalizations and ED visits from HHC.

Public health relevance
PROJECT NARRATIVE The study is the first to explore whether automated speech processing can improve timely identification of home healthcare patients at risk for hospitalization and emergency department visits. In the future, our results can help nurses to identify patients who are deteriorating and to prioritize them for risk reduction interventions.